Transfusion of Prematurity Early School Age Follow-up (TOP 5) DCC

Project Summary
Up to 95% of premature infants undergo red blood cell (RBC) transfusion while in the intensive care unit, yet it
is unknown whether more restrictive or more liberal transfusions will lead to optimal brain development. The
Transfusion of Prematures (TOP) Trial is a multi-center study funded by the NHLBI and supported by the
NICHD Neonatal Research Network (NRN). The primary objective of the TOP Trial is to assess survival and
rates of neurodevelopmental impairment at 22-26 months corrected age in extremely low birth weight (ELBW)
infants that are randomized to either liberal or restrictive RBC transfusion thresholds. The trial began
enrollment in December 2012 and reached the target sample size of 1,824 infants on time in April 2017.
Although major deficits in motor and cognitive function may be detected at 22-26 months of age, these infants
are too young to assess cognitive, behavioral, and coordination skills that, if impaired, can lead to problems
with academic skills, motor performance or adaptive functioning in home or school environments, conditions
that are far more prevalent in this population and create substantial morbidity for the children and their families.
Because optimal transfusion management is a critical knowledge gap in neonatology, the currently proposed
TOP 5 Study will assess functional neurodevelopmental outcomes of infants randomized to two different
transfusion thresholds in the TOP Trial at 5 years corrected age.
The TOP 5 Study Clinical Coordinating Center (CCC) is led by Co-PIs Dr. Peg Nopoulos, who has a ten-year
history of studying the outcomes of premature infants exposed to liberal or restrictive transfusion, and Dr. Sara
DeMauro, who has extensive experience conducting multicenter outcomes studies in collaboration with the
NICHD NRN and the Data Coordinating Center (DCC) at RTI International. The DCC PI Dr. Abhik Das also
leads the DCC for the NICHD NRN. The NRN has a superb track record in school-age outcomes research and
history of productive collaboration with NHLBI. Thus, the TOP 5 Study has been thoughtfully designed to
leverage existing successful research infrastructure, relationships, and resources in order to reduce
redundancy and ensure success. The results of the TOP 5 study will provide evidence about which
approach to neonatal transfusion (liberal or restrictive) minimizes damage to vulnerable neuronal
circuits and, in turn, which transfusion strategy will improve both short and long-term outcomes for
these vulnerable premature infants.

Public health relevance
Project Narrative The Transfusion of Prematures (TOP) Trial randomized 1,824 preterm infants to liberal or restrictive red blood cell transfusions in order to determine which practice might be best for neurodevelopmental outcomes at 2 years. The current “TOP 5 Study” will assess functional neurodevelopmental outcomes of TOP subjects at 5 years of age, an age which will permit detailed assessment of cognitive skills, motor coordination, emotional/behavioral development, and academic readiness. Evaluating which approach to transfusion minimizes damage to vulnerable neuronal circuits is expected to have a significant impact on the clinical management of preterm infants and, in turn, improve both short and long-term outcomes for premature infants.